The urinary microbiome and bladder toxicity after pelvic radiotherapy

Project Summary: Most men diagnosed with prostate cancer (PCa) are 65 years of age or older. Radiotherapy
(RT) is an effective and curative treatment for early-stage PCa. However, 20% of PCa patients can develop late,
often irreversible, chronic adverse side-effects after their RT. Radiation cystitis (RC) is a clinically significant
chronic toxicity. Symptoms of RC include hematuria and urinary dysfunction, including increased urinary
frequency and urgency, incontinence, and dysuria, and these can be significant clinical concerns for the ~3.1
million PCa survivors in the US. These symptoms can be more pronounced in older PCa patients because of
preexisting urinary symptoms and/or reduced functional reserve, putting them at increased risk of dysfunction
after RT induced injury.
RT dose-volume constraints are used to lower the risk of developing a treatment-related toxicity, but the bladder
cannot be avoided completely in the PCa RT treatment plans, and significant variation in the incidence and
severity of RC exists amongst PCa patients which suggests an important role for host factors personal to each
PCa patient. The urinary microbiome is altered in urologic diseases common in older adults, and dysbiosis has
been linked with urinary dysfunction unrelated to infection. But, no studies have investigated the effect of RT on
the urinary microbiome, or the effect of dysbiosis on RC, among PCa patients. Therefore, we hypothesize that
RT-mediated urothelial damage in the bladder that leads to disruption of routine urinary function, and increases
urinary frequency, will produce urinary microbiome dysbiosis, and therefore microbiome dysbiosis could be a
non-invasive urine-based early biomarker of RC. Our clinical genetic studies identified signaling pathways linked
to the microbiome and immune cell recruitment that support this hypothesis. Using banked urine from our
prospective clinical study of RC with up to 5 years of follow-up, as well as our preclinical mouse model of RC,
we have demonstrated we can detect a urinary microbiome despite the low abundance, and we show evidence
of dysbiosis after RT. This project will use banked urine from our clinical study to test the hypothesis that (i) the
microbial composition and/or metabolic potential of the urinary tract is changed by RT, and (ii) dysbiosis and/or
metabolic dysregulation will correlate with patient reported outcomes (PROs) capturing bladder dysfunction
following RT. Then, using our mouse model of RT-induced bladder injury, we will test the hypothesis that (iii)
changes in the microbiome may serve as a potential biomarker of RT injury to the urothelium, and if changes in
microbiome are a response to tissue injury and recruited immune cells. This will be achieved by comparing
dysbiosis with functional micturition, and local and systemic biomarkers of bladder injury, after focal RT to the
entire bladder volume or just bladder trigone. Finally, using banked urine from both our human and mouse
studies, we will evaluate whether a mitigator if radiation-induced bladder injury (angiotensin converting enzyme
inhibitors) exerts its protective effect by altering inflammatory and immune processes thereby avoiding dysbiosis.

Public health relevance
NARRATIVE Prostate cancer patients treated by radiotherapy can experience treatment-related toxicities that have life-long negative effects on health-related quality of life. The proposed studies will investigate if the urinary microbiome changes after radiotherapy, and if any changes correlate with the severity of urothelial toxicity after radiotherapy. These questions will be investigated using both banked urine from prostate cancer patients that experienced bladder toxicities after radiotherapy and urine from mouse studies investigating mechanisms of urothelial toxicity, with the long-term goal of using the microbiome as an inexpensive readout of the susceptibility to radiation toxicity.